Neuroplasticity of Spatial Working Memory in Signed Language Processing

DESCRIPTION (provided by applicant): Signers, when compared to nonsigners, have demonstrated enhanced visuo-spatial processes such as facial discrimination, mental rotation, and spatial maintenance following the learning of a signed language (Bettger, Emmorey, McCullough, & Bellugi, 1997; Emmorey, 2002; Wilson, Bettger, Niculae, & Klima, 1997). The processing of signed, as compared to spoken, language makes unique demands on visuo-spatial cognition because many of the processes involved in everyday sign discourse map onto the known properties of spatial working memory (SWM). As a consequence, exposure to sign language appears to produce unique adaptations to SWM functioning. This adaptive effect has been observed to extend to nonnative signers (Keehner & Gathercole, 2006) but little remains known about the neural foundations of such behavioral outcomes. It is not clear if there is a CP--a hypothesized time frame within which young human brains optimally learn language (Au, Knightly, Jun, & Oh, 2002; Lennenberg, 1967; Newport, 1990; Penfield & Roberts, 1959)-- for learning a signed language. But, we know that early exposure to two languages produces positive, robust impact on neurocognitive development, even possibly prolonging the CP (Jasinska & Petitto, 2013; Kovelman, et al., 2008; Petitto & Kovelman, 2003; Petitto, et. al., 2012). Furthermore, children exposed to two languages during the CP have shown working memory advantage, specifically enhanced executive control in nonverbal tasks (e.g. stroop and simon) (Bialystok, 1999). The bilingual advantage was not found in American Sign Language (ASL)-English bilinguals (Emmorey, Pyers, & Bialystok, 2008), but it might be because the administered nonverbal tasks (directional flanker) in the study didn't tap cognitive functions that are essential for sign language processing such as SWM. Here we ask, whether the timing of sign language acquisition yield changes in the neural resources facilitating SWM. Specifically, we will investigate whether there is a critical period fo the SWM maintenance enhancement found in other studies; and whether there is a critical period for SWM executive inhibition. By studying a spatial syntax based language like ASL, a unique window, that would not be possible with spoken language, is gained into the structural and functional plasticity of the human brain. Furthermore, this study will provide advancement to scientific debate about the nature of brain plasticity and learning across the human lifespan. Furthermore, if we discover that learning a signed language is possible after the critical period, then it may be possible to reverse the CP in adult learners.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of this research is to provide novel insights into the nature of neural plasticity, specifically spatial working memory, when learning signed language occurs after the critical period for language acquisition. Signed language has been shown to have unique neural and cognitive benefits, but its impact on late-learners is not well understood. The significant relationship between signed language and space may provide opportunity to use or enhance parts of the brain that are not activated to the same extent by spoken language. Findings will shed new light on how the signing bilingual brain may reveal the biological extent of the neural architecture underlying all human language and the language processing potential not fully recruited in the monolingual brain. Furthermore, this has a transformative translational impact as many individuals, deaf and hearing, learn signed language for the first time at varying ages across the lifespan.